Molecularly Defined Immunoprobes for Scalable Brain Protein Mapping with Reference Datasets

ABSTRACT
Molecularly Defined Immunoprobes for Scalable Brain Protein Mapping with Reference Datasets
To fully understand brain function and dysfunction, it is essential to map the brain's circuitry from molecules to
cells to circuits. Recent advancements in whole brain tissue clearing have opened new avenues for cellular
mapping at the proteomic level. However, the lack of validated, molecularly defined, renewable reagents has
limited progress in this area.
Monoclonal antibodies (mAbs) serve as effective affinity probes for scalable whole brain proteomic mapping.
Developing a renewable resource of monospecific immunolabelers specifically validated for whole brain cellular
mapping represents a significant step forward in creating reference atlases of the brain. Our project aims to
enhance the dissemination of an existing monoclonal antibody collection by identifying mAbs that effectively
label target proteins in both mouse and human cleared tissues. We will convert these mAbs into recombinant
forms (R-mAbs) for use in generating comprehensive reference datasets for whole mouse brains.
Current limitations in cleared brain immunolabeling hinder the utility of existing antibody collections, which have
not been optimized for these new methodologies. The extensive repository of cryopreserved hybridomas at the
UC Davis/NeuroMab facility, targeting over 500 brain proteins, provides a unique opportunity to broaden the
applicability of this collection to cleared whole brain mapping. Collaborating with Dr. Zhuhao Wu at Cornell, an
expert in whole brain protein mapping, we will identify and validate probes that bind to targets in both mouse and
human cleared brain tissue.
Our approach includes validating sets of R-mAbs for cleared tissue labeling and, in collaboration with AddGene,
disseminating these plasmids and R-mAbs widely within the scientific community. Furthermore, we will generate
a reference dataset for at least two R-mAbs per target in cleared whole mouse brain, which will be made
accessible through a cloud-based platform. This initiative will significantly enhance the availability of these critical
resources and accelerate the pace of brain circuit mapping at various scales.

Public health relevance
NARRATIVE Disseminating a resource of cost effective, renewable and scalable protein binders validated for their utility in cleared brain tissue is critical for the development of reference brain atlases at cellular and subcellular resolution in human and mouse. We address this unmet need by developing cross validated recombinant antibodies validating for their utility in iDISCO cleared mouse and human brain. This resource and reference whole mount brain datasets generated using them will be disseminating to the neuroscience community through partnerships with AddGene and through a cloud based platform at Cornell.